Columbia Population Research Center

Overall Component – Abstract
This application seeks P2C continuation funding for the Columbia Population Research Center (CPRC), co-
directed by Jennifer S. Hirsch (Public Health) and Jane Waldfogel (Social Work). CPRC’s mission is to
increase the scientific impact, innovation, and productivity of population researchers at Columbia, increase
their competitiveness for peer-reviewed external funding in population dynamics research, help junior
population scientists achieve research independence, and maximize the efficiency of funding for population
dynamics research. To achieve that mission, our specific aims are to: 1) nourish a vibrant cross-campus
intellectual community of population dynamics researchers at Columbia, fostering the development of junior
scientists and encouraging collaborations within and across units and disciplines; 2) advance population
dynamics research in CPRC’s five primary research areas (PRAs): children, youth, and families; reproductive
health and HIV/AIDS; immigration/migration; urbanism and neighborhoods; and, new with this renewal, climate
and environment; 3) continue to be a leading population center focused on research on inequalities in the
health and well-being of vulnerable populations and on policies to address those inequalities; and 4) implement
a new partnership to share P2C resources with population dynamics researchers at the City University of New
York (CUNY). The coordinated work of three research infrastructure cores—administrative, computing and
methods, and development—will facilitate cross-disciplinary and cross-campus population dynamics research
at Columbia, with a particular focus on advancing the professional development of junior scientists, and ensure
the CUNY partnership is implemented across the center. From our 2006 start as a “developmental” center with
population scientists at three Columbia University schools (Social Work, Public Health, and Arts & Sciences),
CPRC has grown into a large, cohesive and vibrant university-wide center featuring 93 affiliates (including 39
junior scientists) at 10 schools. Hallmarks of the center are the diversity of our faculty at both the junior and
senior scientist levels; the crucial role of the center in transforming computing infrastructure for population
research at the university; the substantial leveraging of university support, with an institutional commitment of
more than double the total requested NICHD direct costs; affiliates’ success rate with NICHD applications; and
the extraordinary success of our seed grant program in this cycle, with a return on investment that is 18 times
that of the prior cycle (84 vs 4.6). Key innovations in this application include a substantially expanded program
of pre- and post-award grant support for junior scientists, to address the unevenness of grant support across
the university; a new primary research area on climate and environment; and a new partnership with CUNY to
increase access to P2C resources for population scientists at an institution without a P2C funded center.

Public health relevance
Project Narrative The Columbia Population Research Center (CPRC) will contribute to the public’s health by facilitating and supporting collaboration for researchers from across Columbia University who, because they are in different departments, schools, or disciplines, would not otherwise connect. Our activities will enhance affiliates’ research in five primary research areas – children, youth, and families; climate and environment; reproductive health and HIV/AIDS; immigration/migration; and urbanism and neighborhoods – with a cross-cutting focus on inequalities and policies, and a particular emphasis on promoting the development of junior scientists.